EFFECT OF ALPHA TOCOPHEROL AND ALPHA LIPOATE ON LDL OXIDATION

The overall hypothesis is to examine the effect of alpha lipoic acid alone and in combination with alpha tocopherol on plasma and LDL oxidation.